14TH ANNUAL SAN ANTONIO BREAST CANCER SYMPOSIUM

The 14th Annual San Antonio Breast Cancer Symposium is an international meeting featuring state-of-the art lectures by invited speakers and proffered papers on the experimental biology, etiology, prevention, diagnosis and therapy of breast cancer. The symposium features concurrent clinical and basic science sessions as well as clinically oriented panel discussions during lunch. Abstracts accepted for presentation and manuscripts of plenary lectures are published in the journal Breast Cancer Research and Treatment. All symposia to date have .been granted Category 1, AMA credit for continuing education. The 1990 symposium enrolled 529 registrants from twenty-four countries including the United States and Canada.